Development of anti-cancer probes targeting ferroptosis pathway

ABSTRACT.
Conventional cancer chemotherapy typically induces apoptosis, but many tumors become resistant to these
agents by inducing anti-apoptotic pathways. Therefore, anticancer therapies targeting non-apoptotic pathways,
such as ferroptosis, is an exciting field that offer great potential for overcoming cancer chemo-resistance. Our
group is particularly focused on the development of a selective therapeutic strategies based on the ferroptosis
pathway that could complement the existing therapeutics to target hard-to-treat cancers such as non-small cell
lung cancer (NSCLC) that are resistant to conventional therapies. Using a two-stage screening paradigm, the PI
engineered a drug-like nanomolar potent ferroptosis inducer named TKD1079. This compound has high mouse
microsomal stability (T1/2 = 402 min) and low plasma clearance (Clint = 1.7 μL/min/mg). Mechanistically,
TKD1079 induces ferroptosis selectively instead of apoptosis by causing glutathione peroxidase 4 (GPX4)
depletion. TKD1079 triggered ferroptosis in both human fibrosarcoma HT-1080 and adenocarcinoma lung NCI-
H23 cancer cell lines while sparing normal, healthy cells (Beas-2B) with 500-fold therapeutic index (TI). Cell
death induced by TKD1079 was fully suppressed by the canonical ferroptosis inhibitors deferoxamine and -
tocopherol, indicating that it specifically induces ferroptosis. However, the solubility of TKD1079 is low (1.3 M
in PBS) and engineering TKD1079 analogs with improved drug like properties including better solubility is
required for in vivo studies. Our central hypothesis is that a version of TKD1079 that preserves pro-ferroptosis
activity but with increased potency, solubility and stability will be useful to overcome apoptosis/chemo-resistance
in hard-to-treat cancers such as NSCLC. We will address this hypothesis by exploring two specific aims: (1) SAR
study of first-in-class ferroptosis inducers based on TKD1079 scaffold, and (2) identify the optimal top 2-3
TKD1079 analogs that drive ferroptosis selectively in vitro with improved pharmaceutical properties. Successful
completion of this proposed work will facilitate the development of a first-in-class TKD1079 analogs that retain
the many positive features of TKD1079 and possess improved solubility for lung cancer therapeutics that trigger
ferroptosis and will propel their development towards pre-clinical application.

Public health relevance
Project narrative: The proposed studies are designed to discover first-in-class ferroptosis-inducers of well- defined cell death and uncover their target for cancer treatments. In addition, these studies will improve possible resistance that increases towards agents activating a known apoptosis cell death. Thus, completion of these studies will provide knowledge that can be used to increase drug efficiency against hard-to-treat cancers such as lung cancer.